Interneurons as Early Drivers of Huntington´s Disease Progression

Huntington’s disease (HD) is an insidious neurodegenerative disorder caused by trinucleotide repeat expansion
in exon 1 of the gene that codes for Huntingtin (mHtt). The pathogenic mechanisms underlying HD remain poorly
understood. Studies of HD models have documented numerous developmental impairments during ‘pre-
manifest’ HD. Using conditional HD models, the Mehler laboratory team has previously shown that such
developmental processes mediate disease pathogenesis. Now, this team provides evidence demonstrating that
interneuron neurogenesis is prominently disrupted in mouse models of HD, leading to deficits in the complement
of these interneurons within the developing cerebral cortex. Such deficits are of great importance, as studies
have shown these lead to permanent changes in cortico-striatal connectivity laying the foundation for cortical
hyperexcitability, impaired excitation-inhibition coupling, and striatal excitotoxic stress later in life. Although
cortical interneuron deficits have previously been reported in HD cases, their role in HD pathogenesis has never
been further interrogated. This application tests the central hypothesis that HD is caused by impairments in the
developmental elaboration of selective cortical interneuron subtypes; therefore, prevention of the adverse
developmental effects of these interneuron deficits will ameliorate or even prevent disease occurrence. This
hypothesis is further supported by preliminary data showing that genetic rescue of developing interneurons
precludes the onset of characteristic features of HD in BACHD mice: motor coordination deficits, hypomyelination
of subcortical white matter tracts and striatal degeneration. Specific Aim 1 (SA1) initially defines whether
interneuron progenitor cell supplementation via heterochronic grafts into mutant neonatal pups favorably
modifies the occurrence of motor deficits and striatal degeneration, two distinctive traits of HD. This aim also
examines whether the role of interneurons in disease progression takes place at the expense of quantitative
deficits or through additional factors associated with expression of mutant huntingtin in these cells. SA2
interrogates the interneuron-dependent pathogenic mechanisms mediating HD, focusing on putative modulatory
effects of GABA, Reelin and complementary ligand release. Finally, SA3 employs a large array of HD
postmortem specimens from two major brain banks to define the role in disease progression of cortical
interneuron deficits. This aim also interrogates whether known HD genetic modifiers, including trinucleotide
expansion length and/or polymorphisms of DNA damage response genes modulate the extent of interneuron
alterations, as well as whether these cells mediate the predictive effects of these genetic modifiers on age at
disease onset/progression. Overall, confirmation of the central hypothesis would have substantial implications
for the field, as it will provide strong evidence regarding the intersectional roles of interneurons in HD
pathogenesis and also define a novel early-stage therapeutic window for preventing HD onset and progression
for a neurodegenerative disorder currently lacking substantive and effective therapeutic interventions.

Public health relevance
The proposed research is relevant to public health because it would implement a novel proof-of-principle experimental strategy to ameliorate Huntington’s disease (HD) onset and progression: innovative developmental cell transplantation approaches employing the wild-type counterpart of affected cortical interneuron progenitor cells to promote restoration of impaired cortico-striatal functions rather than traditional regenerative approaches to replace defective cell types during the active phase of the disease. Accordingly, this research addresses a knowledge gap that is relevant to the goals of the overall NIH strategic mission, namely the absence of understanding of the requisite HD developmental targets and mechanisms amenable to disease-modifying interventions for neurodegenerative diseases. By targeting early cellular maturational impairments that promote late-onset disease, this approach will enhance the restoration of neural network functions during the critical period of developmental plasticity and the pre-manifest phase of illness prior to the onset of irrevocable disease dysfunction.